Neurobiological mechanisms underlying resiliency and vulnerability to opioid use disorder

PROJECT SUMMARY/ABSTRACT
There has been a significant rise in opioid use disorder (OUD) in the United States over the past decade, making
it imperative to gain a better understanding of the behavioral characteristics underlying OUD vulnerability.
Current rodent models focus on how one or few traits interact in a linear manner to predict substance use disorder
(SUD), however, OUD consists of several symptoms that interact with one another across the addiction process
and can vary between individuals to affect OUD vulnerability or resiliency. I contributed toward a rat model that
captures this behavioral complexity using male and female heterogeneous stock rats in an effort to better model
human OUD. Bayesian stochastic block model (SBM) network-based clustering analysis is used to separate rats
into resilient and vulnerable subpopulations. Using this model, we are able to assess the neurobiological
mechanisms contributing toward OUD vulnerability and resiliency, the latter of which is not well understood.
These opposing phenotypes are likely mediated by different cellular and circuitry adaptations, and will be the
focus of this proposal. The K99 aims assess how functional and morphological neuroplasticity differences in
nucleus accumbens core (NAcc) D1/D2 medium-spiny neuron (MSN) contribute to OUD resiliency and
vulnerability. I will first use whole-cell patch-clamp electrophysiology to characterize changes in AMPA/NMDA
ratios in vulnerable and resilient subpopulations following cued reinstatement (Aim 1). I will then inject an
intracellular label into the recorded cell and examine differences in D1/D2-MSN dendritic spine morphology (Aim
2). This approach will allow for the tracking of NAcc neuroplastic adaptations within the same cell across the two
phenotypes. The R00 portion of the proposal will assess how pathway specific regulation of dorsolateral ventral
pallidum (dlVP) projections contribute to OUD resiliency and vulnerability. Comparable to the NAcc, the dlVP,
the main functional output of the NAcc, shows cell-specific functional regulation of drug seeking and refraining
behavior, making it an ideal structure to evaluate circuit heterogeneity in individual variation in OUD propensity.
Using confocal microscopy and viral tracers, I will assess functional connectivity from the dlVP to the subthalamic
nucleus (STN), a region known to enhance seeking and likely vulnerability, and to the lateral habenula (LHb),
known to mediate aversion and hypothesized to promote resiliency (Aim 3a). I will then employ chemogenetic
technology to selectively isolate and manipulate these pathways in OUD resilient and vulnerable rats. (Aim 3b).
Lastly, using whole-cell patch-clamp electrophysiology, I will evaluate input adaptations in the STN and LHb
following dlVP stimulation within the two phenotypes following cued reinstatement (Aim 4). Experiments in this
proposal employ a novel rat model capturing individual variation in OUD propensity similar to what is observed
in humans. Work from this proposal will greatly contribute to our knowledge of the cellular and circuitry
mechanisms contributing to OUD resiliency versus vulnerability.

Public health relevance
PROJECT NARRATIVE Opioid use disorder (OUD) is a complex multi-symptomatic disorder whereby traits non-linearly interact on an individual basis across the OUD phases influencing vulnerability and resiliency. Using a novel rat model capturing this behavioral heterogeneity present in human OUD, cell- and pathway- specific adaptions underlying OUD propensity will be characterized. Work from this proposal will contribute to disentangling the neurobiological and behavioral complexities associated with OUD vulnerability, yielding valuable insight into the compensatory mechanisms in place to promote resiliency.